Investigating the Role of AIMP2 in Cardiac Stress Responses

PROJECT SUMMARY/ABSTRACT
Cardiovascular disease is the leading cause of mortality worldwide, driven by factors such as hypertension,
myocardial infarction, and genetic predispositions. Despite its prevalence, the molecular mechanisms underlying
cardiac stress responses remain poorly understood. AIMP2, a core component of the multisynthetase complex
(MSC), is implicated in protein synthesis regulation and cellular stress responses, but its role in maintaining
cardiac homeostasis has not been elucidated. This project investigates the hypothesis that AIMP2 supports
adaptive cardiac responses to stress by stabilizing MSC components and regulating protein synthesis. Aim 1 will
assess the impact of AIMP2 on cardiac function through gain- and loss-of-function approaches, utilizing
cardiomyocyte-specific AIMP2 knockout (AIMP2-cKO) mice and stress-induced rescue experiments. Aim 2 will
explore the mechanistic role of AIMP2 in protein synthesis regulation, focusing on its influence on MSC stability,
protein synthesis during cardiac stress, and functional rescue experiments in AIMP2-deficient cells. By
integrating in vivo and ex vivo approaches, this research will provide critical insights into how AIMP2 modulates
cardiac stress responses. The findings could uncover novel therapeutic strategies to mitigate heart disease
progression by targeting the MSC and its regulatory components. The project will be conducted in the laboratory
of Dr. Federica Accornero, a leader in post-transcriptional regulation of cardiac remodeling, providing a robust
training environment in this emerging area of cardiac biology.

Public health relevance
Project Narrative This research aims to uncover the role of AIMP2 in heart disease by investigating its impact on protein synthesis and stress responses in cardiomyocytes. By examining both the loss and gain of AIMP2 function, this study seeks to uncover how AIMP2 supports cardiac health and adapts to stress. The findings will inform the development of novel therapeutic approaches for cardiovascular disease, addressing one of the leading causes of mortality worldwide.